Administrative Core

The Administrative (ADMIN) Core will coordinate and integrate the research cores of the Indiana Center for Musculoskeletal Health–Basic Science Research Center (ICMH-BSRC) with all center activities, will ensure effective communication between all internal and external components, and will be responsible for arranging oversight bodies to monitor progress and efficiency. In addition, the ADMIN Core will administer the Enrichment Program, designed to identify and support new investigator funding, new collaborations, feasibility proposals, and innovation initiatives. Other initiatives will include reaching out to other P30 Directors to share information in order to advance the field as a whole. To accomplish these responsibilities, the specific aims of this core include the following: Aim 1: Provide administrative support to the resource cores. Here, the ADMIN core will provide overall administrative support to the program, including budget construction and management, account updates, coordination of institutional support and scientific/project meetings, and liaison to the oversight boards. Aim 2: Provide statistical support and data management to the resource cores. Here, the ADMIN core will provide study design consultation, data management strategies, and statistical support services to projects supported by the resource cores and pilot projects. Aim 3: Serve as a liaison between the ICMH-BSRC and the multitude of other relevant units on campus to maximize interaction, synergy, and growth. Here, the Admin Core will serve as the lead contact for ICMH-BSRC interaction with the highly fortified resource environment at IU that comprises other functional units. Aim 4: Administer pilot grant programs that fund the use of the resource cores. Here, the ADMIN core will administer pilot funding for new, collaborative, innovative projects that involve core usage and also funding for our pipeline/retention programs to fortify the MSK workforce into the future. Aim 5: Provide communications, education, and outreach for the resource cores. Here, the ADMIN core will engage in outreach to the broader community including undergraduate and high school students, as well as other research groups around the country whose programs would benefit from our core services. In summary, the ADMIN core will facilitate basic science research by supporting MSK investigators, providing a roadmap of existing resources for the conduct of basic research, and training investigators in study design, measurement techniques, methodologies, and outcome measures in musculoskeletal science. It will serve as a critical resource that will enhance and grow basic MSK research across Indiana and beyond.